Technology-based training to improve learning-to-drive outcomes for autistic persons

Project Summary/Abstract
The goal of the proposed project is to make the widespread use of an autistic driver training program feasible.
Specifically, we plan in phase I to develop an innovative learn-as-you-go training module and in phase II to
rewrite the app for a variety of devices and operating systems. The program teaches visual search skills to
autistic individuals who are learning to drive. The lack of a training module limits the widespread use and
implementation of this important program. One in 54 children in the U.S. are diagnosed with autism spectrum
disorder and ≈50,000 autistic teens transition out of special education annually. Learning to drive can significantly
improve autistic teens' quality of life, ability to seek employment and engagement in social activities, thereby
improving their physical and mental health. Autistic teens can learn to drive safely with additional supports
beyond traditional driver training programs. In particular, autistic teens need more support to develop effective
visual search skills that allow them to effectively follow rules, prioritize critical information and avoid road hazards.
This is of particular importance to teen drivers, as motor vehicle crashes are the leading cause of death and
acquired disability among U.S. teens. One-third of all at-fault crashes among teen drivers is due to the teen not
responding to road hazards appropriately. There is a critical need for tools that effectively train autistic teen
drivers to recognize and avoid road hazards.

Public health relevance
Project Narrative The project relates to the development of technology to reduce the rate of motor vehicle crashes and motor vehicle crash related injuries and deaths. We hypothesize that developing this program for widespread implementation will support autistic teens in becoming effective drivers by teaching them critical driving skills and reducing their anxiety about driving. This is highly significant as motor vehicle crashes are the leading cause of death among teens in the U.S.